RNA Structural Motif Analysis Revisited: Towards a Systematic Understanding of Noncoding RNA as Modular Biomolecules

Project Summary
Non-coding RNAs (ncRNAs) play crucial roles in catalysis, gene expression regulation, RNA splicing, and
various other biological processes. Their functions are facilitated by their unique 3D structures, which include
recurrent substructural components known as RNA structural motifs (RSMs). RSMs are conserved in sequence
composition, base interaction patterns, and 3D geometry, serving as fundamental building blocks of RNA
structure and function. The dysfunction of RSMs has been linked to various diseases, highlighting the importance
of studying these motifs to understand RNA-related diseases and develop potential cures. Our previous NIH-
funded research established a strong connection between RSMs and their distinctive base interaction patterns
(pairing and stacking). We developed computational methods for detecting and clustering RSMs based on these
patterns. This interaction pattern-centric approach is more sensitive, allowing for geometrical variation among
functional homologs, and faster, as it bypasses the need to superimpose RSMs. However, predicting base
interactions remains imperfect, making it challenging to distinguish between function-preserving covariations and
annotation errors. To address this, we will develop a more accurate base interaction annotation framework by
reframing the problem as a 3D point cloud object detection problem in computer vision. With improved base
interaction patterns, we expect to identify more RSM instances from the growing repository of RNA 3D structures
in the Protein Data Bank (PDB). This expanded collection will enable the categorization of RSMs, crucial for
defining function-determining characteristics and understanding permissible variations in different residues. We
propose a de novo clustering method based on similarities in both base interaction patterns and 3D geometry.
Additionally, we will develop algorithms to compare RSM families and explore their organizational architecture -
whether hierarchical with superfamilies and subfamilies or flat with near-equally distinct families. Using this
knowledge, we will quantify RSM family conservations and variations by constructing probabilistic profiles. These
profiles will facilitate the detection of RSM-encoding regions in multiple aligned genomic sequences. Coupled
with secondary structure information, we will define a novel representation for RNA structure: the RSM-enriched
Secondary Structure (RSMe-SS). We hypothesize that RSMe-SS will be informative for functional inference. To
support the hypothesis, we will construct a mathematical model connecting RSMe-SS with molecular functions.
If successful, this approach could revolutionize medical genomics by enabling reference-independent functional
investigation of novel ncRNA biomarkers and SNPs discovered in high-throughput experiments. In summary, we
propose an in-depth study of RSM and extend its applications to ncRNA functional inference in sequence data.
This project aims to elucidate fundamental RNA structure-function relationships, significantly impacting basic
science. It will also advance medical research by extending the scope of medical genomics beyond proteins to
include ncRNAs.

Public health relevance
Project Narrative RNA structural motifs are components in non-coding RNAs, whose dysfunction will result in physiological disorders and cause diseases (such as Dyskeratosis congenita and Prader-Willi syndrome). We plan to devise a suite of computational methods for refining RNA structural motif search, classification, and discovery, and further expanding the resulting findings for functional prediction of non-coding RNA genes. The proposed activities, if successful, will deepen our understanding of RNA structural organization and its functional implications, enabling reference-independent mechanistic studies of the non-coding RNA biomarkers and SNPs.